Preclinical testing of early life anti-myostatin therapy for osteogenesis imperfecta

Summary: Osteogenesis imperfecta (OI) is a genetically and clinically heterogeneous connective tissue disorder
resulting in muscle weakness, bone deformity and increased fragility, primarily due to type I collagen gene mutations.
Genetic and clinical heterogeneity (> 1500 mutations) and growing evidence of mutation specific pathogenesis further
challenges therapeutic strategies. OI mutations can be detected by commercial cell-free DNA screening tests in
maternal serum which are generally conducted at 10 weeks gestation, and severe OI is most often detected by standard
ultrasound screening at 18-20 weeks. However, current treatment is limited to surgical rodding or bisphosphonates in
older children. There is no cure. Previously, we showed by pharmacological inhibition of myostatin (a negative
regulator of muscle mass) beginning at 5 weeks of age improved bone parameters in two mouse models of OI.
However, more significant improvements were achieved when OI mice were also genetically deficient for myostatin,
suggesting prenatal and/or early life myostatin inhibition is critical for maximum efficacy. Furthermore, by three
independent approaches, we demonstrated that reduced maternal myostatin during pregnancy improved bone geometry
and biomechanical integrity in offspring: 1) Wildtype (Wt) offspring born to dams with reduced myostatin (+/mstn)
had stronger bones than Wt offspring born to Wt dams; 2) Mice with osteogenesis imperfecta (+/oim) had stronger
bones when born to +/mstn dams than when born to +/oim dams; and 3) +/oim blastocysts transferred to +/mstn
recipient dams had stronger bones as adults than those transferred to +/oim dams. Importantly, the last approach
demonstrated through embryo transfer experiments that the maternal +/mstn effect on offspring bone is conferred by
the uteroplacental environment during pregnancy. Based on these findings, we will test the efficacy of
pharmacological inhibition of maternal and fetal myostatin during either pregnancy or lactation or throughout
pregnancy, lactation and early adulthood via anti-myostatin monoclonal antibody treatment in two molecularly distinct
OI mouse models. The primary outcome measures and indicators of efficacy are improved musculoskeletal health
(skeletal muscle and bone mass and strength) of Wt and OI offspring just prior to birth, at four weeks of age and at
peak bone mass (4-month-old), as well as maternal metabolic and musculoskeletal health during pregnancy and
lactation. The proposed project will provide preclinical evaluation of an innovative therapy for osteogenesis
imperfecta during two critical developmental periods for lifelong musculoskeletal health.

Public health relevance
Public Health Relevance: The proposed project will test an innovative monoclonal antibody-based therapy for osteogenesis imperfecta, a congenital disorder known as brittle bone disease. It will use two mouse models of OI to determine whether the prenatal and/or neonatal periods are especially responsive to treatment.